Role of 3D chromatin architecture in axonal regeneration following peripheral nerve injury

PROJECT SUMMARY/ABSTRACT
Nerve injuries are highly prevalent worldwide and are associated with sensory and motor impairment,
neuropathic pain, and permanent disability, resulting in significant health burden and costs for the healthcare
system. While axons in the peripheral nerves can regenerate following an injury, their growth rate is too slow for
successful functional recovery. The study of the molecular mechanisms regulating the regenerative capacity of
the peripheral axons is paramount to provide insights for strategies aimed at boosting their regenerative potential.
One key factor for long-distance regeneration of peripheral axons is the transcriptional reprogramming of
neurons into a growing state, involving activation of regenerative gene networks. For this reason, epigenetic
mechanisms that broadly open the chromatin, affecting the expression of multiple genes, are preferred
therapeutical targets to enhance nerve regeneration. The folding of the genome into three-dimensional
topologically associating domains (TADs) allows coordinated changes in gene expression in response to specific
inputs, by facilitating the interaction between gene promoters and regulatory enhancers. Our unpublished data
in mouse dorsal root ganglia sensory neurons show that the full activation of regenerative genes after nerve
injury depends on regulated chromatin interactions within TADs. Thus, we hypothesize that TADs and the
enhancer–promoter interactions formed in response to nerve injury regulate the regenerative program.
Furthermore, we hypothesize that modulating TADs and enhancer–promoter interactions can represent a novel
therapeutical approach to enhance nerve regeneration. In Aim 1, we will use high-throughput transcriptomics
and genome-wide mapping methodologies in isolated mouse dorsal root ganglia neurons following sciatic nerve
crush injury or sham control to investigate the molecular mechanisms by which enhancer–promoter interactions
generated in response to injury can promote regenerative gene transcription. We will identify novel molecular
modulators of these genomic interactions, and we will perform functional studies to investigate their role in axon
regeneration. In Aim 2, we will use super-resolution imaging, biochemical, and genome-wide mapping
approaches to identify regulators of the transcription machinery at these chromatin contacts. We will perform
functional studies to investigate their role in axon growth. In Aim 3, we will characterize known regulators of
TADs and address the extent to which these regulators can be manipulated to enhance nerve
regeneration. Findings from this project will add critical knowledge about how regenerative gene expression is
regulated by genome conformation, providing key insights into how to activate the regenerative program in a
specific and sustained way to promote axonal regeneration and relieve the burden of nerve injury.

Public health relevance
PROJECT NARRATIVE Nerve injuries blight the lives of millions of people and are a significant economic burden for global healthcare systems; more in-depth understanding of the mechanisms controlling nerve regeneration is needed to find tools to boost their regenerative potential and enable functional recovery. This research will discover novel pathways to facilitate nerve repair after injury by examining how genome conformation controls expression of genes important for nerve regeneration. Findings from this project will provide key insights into how to activate the regenerative program in a specific and sustained way to promote axonal regeneration and relieve the burden of nerve injury.